The Institute for Health Equity Research Catalyst Center

PROJECT SUMMARY/ABSTRACT
Examining the complex drivers of health disparities requires a diverse research workforce trained in the
transdisciplinary frameworks designed to address multiple domains and levels of influence and adept at
employing health equity research methods. In 2020, the Icahn School of Medicine at Mount Sinai (ISMMS)
created the Institute for Health Equity Research (IHER) to lead health disparities research across the institution
and beyond. IHER faculty have extensive expertise in promoting inclusive excellence, providing training in health
equity science methodology, and fostering academic-community partnerships with key stakeholders to ensure
that community-informed disparities research is conducted and can lead to sustainable change. The overarching
goal of the Catalyst Center Investigator Development Core (IDC) is to integrate faculty enhancement activities
across the institution with the development and implementation of a pilot project program for early-stage
investigators focused on health disparities research. The IDC will provide transdisciplinary educational programs
and health equity research consultation services for investigators at all levels, and from all demographic and
scientific backgrounds. The Catalyst Pilot Project Program will combine individualized mentoring; a curriculum
of MH/HD research skills development; community engagement training; support for producing competitive
future grant applications; and formal and informal opportunities for networking across the institution, and with
local communities and policy makers. The IDC will achieve three aims: (1) Catalyze efforts to conduct health
disparities research by faculty at all levels at Mount Sinai. We will provide methodology workshops and health
equity topics seminars; sponsor a determinants of health journal club; provide opportunities to engage with
community; and create a repository of resources. (2) Develop and implement a Pilot Project Program awarding
3 grants annually. Proposed pilot projects must: a) focus on our priority populations (i.e., racial/ethnic minorities,
socioeconomically disadvantaged individuals, and/or sexual and gender minorities); b) address domains and
levels of influence in the NIMHD framework; c) use principles of community engaged research; and d) aim to
generate preliminary data for a mentored K or R01 submission. With support from a Catalyst faculty health equity
mentor, Catalyst Scholars will develop an individual development plan (IDP), present their proposal to the
Catalyst Community Board (CCB), participate in professional development activities (e.g., research project
management, etc.), and work with the CCB on dissemination strategies. (3) Collaborate with the AC and CEDC
to conduct a comprehensive evaluation of all IDC programs/activities, including faculty confidence and interest
in conducting MH/HD research. The IDC’s cohesive program of educational offerings and resources will increase
the capacity of faculty at our institution to conduct rigorous, community-informed MH/HD research and support
career development of ESIs pursuing careers in health equity science. These programs can serve as models for
other institutions committed to inclusive excellence and advancing health equity research.